Quality of Communication with Parents of Critically Ill Infants

Project Summary/Abstract
This Mentored Clinical Scientist Research Career Development Award (K23) is designed to prepare
Katherine Guttmann, MD, MBE, Assistant Professor and Attending Physician at the Icahn School of Medicine
at Mount Sinai (ISMMS) and the Mount Sinai Hospital to achieve her career goal of becoming an independent
researcher focused on communication between parents of infants and providers in the Neonatal Intensive Care
Unit (NICU) or Pediatric Intensive Care Unit (PICU). She is driven by the overarching aim of improving
communication between parents of critically ill infants and clinicians to enhance decision-making and optimize
outcomes for children and families. In the short term, she seeks to secure the mentorship, training, and
experience to successfully compete for R01 grants designed to improve communication between parents of
critically ill infants and providers in order to improve parent and patient outcomes. To achieve these goals and
transition to independence, Dr. Guttmann and her mentors have developed a detailed career development plan
comprised of: (1) mentorship from a team with whom she has collaborated and published impactful work; (2)
advanced training in family-centered communication, outcomes research methods, and implementation
science; (3) mentored leadership training, and (4) an innovative research plan to define high quality
communication with parents of critically ill infants, validate a measure of communication quality for such
parents, and explore the impact of poor quality communication in the ICU.
Intensive Care Unit admission creates psychosocial morbidity for parents of critically ill infants.
Extrapolating from studies in adult contexts, the long-term impact of poor communication in the NICU or PICU
is likely lasting and negative yet the depth and breadth of the impact of communication quality on parents and
infants is not known. Communication in pediatric settings serves unique functions yet it is incompletely
understood and there is not a high quality validated measure of communication quality specific to critically ill
infants with parents of
critically ill infants; 2) evaluating the psychometric properties and validity of a communication quality measure
in parents of critically ill infants; and 3) exploring the long-term impact of ICU communication on parents.
The proposed K23 will address a fundamentally important gap: lack of knowledge regarding quality of
communication with parents of critically ill infants and its impact on families. The findings from this work will
directly inform future R01 proposals which seek to improve communication in order to improve patient and
family outcomes. career development plan delineates a carefully constructed approach to
acquiring the skillset, expertise, and experience needed to become an independent researcher and a leader in
communication quality research.

Public health relevance
Project Narrative Evidence suggests the long term impact of poor communication with parents of critically ill infants may be lasting and negative. However, not enough is known about high quality communication with parents of critically ill infants: what it is, how to measure it, and how it impacts parents. This proposal seeks to 1) define high quality communication with parents of critically ill infants; 2) evaluate the psychometric properties and validity of a measure of high-quality communication for parents of critically ill infants; and 3) explore the long-term impact of communication in the ICU on parents of ICU patients.